Examination of Myopia Progression and Consequences and Mechanism of Soft Multifocal Contact Lens Myopia Control - Data Coordinating Center

This is the proposal for the Data Coordinating Center for the BLINK2 Study, whose primary goal is to
determine correlates of myopia progression using non-invasive measurement of biomarkers (choroidal
thickness and intrinsically photosensitive retinal ganglion cell-mediated pupil function) and outdoor light
exposure in children. If multifocal contact lenses slow the progression of myopia by 30% or more compared to
single vision contact lenses during the BLINK Study, we will also answer important questions about the
consequences and mechanism of the treatment effect, such as whether multifocal contact lens wear alters
accommodative function and whether or not the treatment benefit is transient. Specifically, we will investigate
whether myopia progression is slowed or simply delayed by multifocal contact lens wear and whether there is a
“rebound” in myopia progression, an increase in progression rate, after discontinuation of multifocal contact
lenses.
The study will identify the myopic children who will most benefit from myopia control by determining those
who are most likely to progress, thereby maximizing the potential for benefit and minimizing risk. BLINK2 will
accomplish this goal by investigating the effect on progression of the most important ocular and environmental
risk factors recently hypothesized to control the growth of the eye. The project will collect the most extensive
longitudinal dataset ever on choroidal thickness in childhood myopia. The study will test the important question
of whether time outdoors and light exposure influence myopia progression after onset in addition to whether
these affects are mediated by intrinsically photosensitive retinal ganglion cells. If soft multifocal contact lenses
show a clinically meaningful slowing of myopia progression during the BLINK Study, the study will also answer
many important questions asked routinely by our clinical colleagues. We will know the accommodative effect of
multiple years of multifocal contact lens wear in children; we will know if multifocal contact lenses slow or
simply delay myopia progression; and we will know whether myopia progression increases following
discontinuation of soft multifocal contact lens wear.
Answers to the questions addressed by this proposal could improve the care for the 60 million myopic
children in the United States. While the consequences of ordinary amounts of myopia are rarely sight-
threatening, the quality of life for all myopic patients is negatively affected and the health care costs to treat
myopia are high (approximately $4.6 billion in 1990). The National Eye Institute recognizes the need to
"evaluate the efficacy of potential treatments for delaying the onset or for slowing the progression of myopia,
such as lenses that alter peripheral defocus." BLINK 2 seeks to maximize the benefit while lowering the risk of
multifocal contact lens wear for myopia control while answering important scientific and clinical questions about
the consequences and mechanism of myopia progression, a problem that affects a large proportion of people.

Public health relevance
Project Narrative Myopia affects approximately one-third of people in the United States, and approximately 60% (60 million) of them become myopic during childhood. The results of this study have the potential to affect the standard of care for young myopic children, and the results will lead to important information regarding features of the eye and factors in the environment that may affect myopia progression.